RISPERIDONE IN TREATMENT OF PSYCHOTIC LIKE &DEFICIT SYMPTOMS

The objectives of this study are to determine the efficacy of risperidone compared to placebo in the treatment of the psychotic-like and deficit symptoms of schizotypal personality disorder (SPD).